Developing Tools to Understand an Alternative Fate of Urate in Neurodegenerative Diseases

ABSTRACT
Urate is the salt form of uric acid predominantly found in the circulation and is considered a major plasma
antioxidant. Low levels of serum urate at diagnosis are associated with accelerated disease progression and
lower patient survival in several neurodegenerative diseases. For example, urate levels are lower in Parkinson’s
Disease (PD) patients and this correlates with loss of the striatal dopamine transporter and an advanced clinical
progression in motor deficits. Similarly, several studies have suggested that urate levels may offer value as a
prognostic biomarker for Amyotrophic Lateral Sclerosis (ALS) progression, yet it remains unclear why low uric
acid reflects poor survival. Recently, a large effort to increase urate levels (inosine supplementation) in PD
patients offered no clinical benefit or improvement in patient outcomes. Why does the supplementation of a major
plasma antioxidant confer no benefit to patients in diseases where oxidative stress is known to be present?
Our expertise in studying the chemical modification of proteins by metabolites led us to consider an alternative
fate of urate when oxidative stress may overwhelm the regeneration of urate antioxidant capacity. We
hypothesize that low plasma urate instead reflects increased oxidation of urate to generate reactive urate radicals
that can chemically modify protein lysine residues, altering protein structure or function, a process known as
protein uratylation. The balance between urate antioxidant benefit, and urate oxidation to damaging radicals,
may uniquely depend on the location and nature of the oxidative stress. In this R03 we are embarking on
exploratory studies to better understand why urate therapy may not have been as successful as anticipated. Our
goal is to generate and validate new tools that will assist movement disorders researchers in the future in testing
the relevance of protein uratylation across a range of preclinical models and human biospecimens.

Public health relevance
PROJECT NARRATIVE Higher levels of serum urate are associated with slower disease progression and improved survival in several neurodegenerative movement disorders, suggesting that urate levels may have prognostic utility in Parkinson’s Disease or Amyotrophic Lateral Sclerosis. Despite this, urate elevation therapy does not slow clinical disease progression. In this proposal we suggest an alternative fate of urate that may better explain why urate levels are low early in the disease diagnosis, and we propose to develop tools to better characterize this process.